MULTIANALYTE IFA FOR CYTOKINES BY FLOW CYTOMETRY

Cytokines are intimately involved with immune response and immunopathology. Research leading to the development of clinically relevant assays has been hindered by the sensitivity and versatility limitations of the ELISA assay. The aim of this proposal is to develop a flow cytometry based ultra-sensitive solid phase immunofluorescent assay system for measuring the level of cytokines in non-pathologic and pathologic plasma, serum samples, or culture supernatants. Assays have been developed for IL-I alpha, IL-2, IL-4, TNF-alpha, and GM-CSF which can enable detection of less than 100 fg/ml and can be completed in l hour. The assay uses antibody-coated paramagnetic microparticles for analyte capture and a fluorescently labeled reporter antibody. Analyte concentration is proportional to fluorerescence. Different fluorochromes conjugated to the reporter antibodies and two different sized particles enabled simultaneous analysis of all 5 analytes. The focus of this proposal is to obtain optimal antibody pairs, define sensitivity levels and assay limitations, and to increase the number of different cytokine assays up to 15. This proposal will lead to the development of a series of products for Cytokine analysis and other analytes which can measure clinically relevant cytokine concentrations. PROPOSED COMMERCIAL APPLICATION: Development of microparticle based ultra-sensitive immunofluorescent assays capable of measuring multiple cytokines simultaneously by flow cytometry for the basic and clinical research market. These assays may be used for establishing normal ranges as well as pathologically associated changes, in cytokine levels and profiles, which in turn may result in clinical test kits.